LARGE AREA DIGITAL IMAGING SYSTEM FOR MAMMOGRAPHY

In mammography, early detection of breast cancer is dependent upon the ability of the imaging system to resolve characteristic distributions and shapes of small microcalcifications in the breast tissue, since approximately 80% of excised breast cancers show areas of calcification on histologic examination. The medical community has not been satisfied with the imaging performance of standard film-screen in its ability to produce the required quality images. Recently, there has been a desire to resolve 50 micromoles structures with very high detection efficiency. The proposed technique would allow a very high spatial resolution, superior to slow film-screen, with an efficiency greater than fast film- screen. A microstructured scintillator film would allow images to be obtained with a lower dose than film-screen, while the digital nature of the image would permit a wide dynamic range as well as the possibility of image enhancement. The use of a modified low noise amorphous silicon (a- Si:H) detector technology which takes advantage of the high scintillator light output will permit high quality digital imaging systems of 3Ocm x 3Ocm, comparable in area to film-based systems, and much larger than conventional technology currently employed in commercial digital imaging systems. The research proposed here would enable the development of an initial prototype of such a high performance mammographic imaging system. Specifically we propose to develop large-area high resolution structured scintillator screens and low-noise a-Si:H detectors needed to carry out this objective.